Advancing a Bio-Psycho-Social Alcohol Treatment Research and Mentoring Program

DESCRIPTION (provided by applicant): This is a new application for a Senior Research and Mentorship Award (K05). The candidate, Peter M. Monti, Distinguished Professor of Alcohol and Addiction Studies, Director, Center for Alcohol and Addiction Studies and Head of the Behavioral and Social Sciences Section at Brown University, proposes an initial period of intense research mentoring to four outstanding Brown University scientists in his Center and a shift in his research program to youth and young adults. Therefore, Dr. Monti proposes to transition from a VA Senior Career Scientist Award to the K05. Mentees and Mentoring Plan. One of the proposed mentees, Don Operario (a social psychologist) was recently recruited from Oxford University and is in a tenure-track position. The other two proposed faculty mentees, Robert Miranda (a clinical psychologist) and Tara White (a neuroscientist) are on a research track. While all three have excellent publication records, only Miranda has published alcohol papers and has received funding from NIAAA (a K23 and 2 R21s). Operario and White are NIDA-funded. None have been funded at the R01 level from NIAAA, though all three have demonstrated strong interest in becoming alcohol researchers. Miranda is furthest along, though both Operario and White have submitted alcohol applications as part of the candidate's pending P60 Center Grant Proposal. The fourth mentee, Margie Skeer (a social epidemiologist) is a postdoctoral candidate working with Monti. She too has a strong publication record. However, she has only just published her first alcohol manuscript, though she has indicated interest in alcohol, as this was her reason for coming to Brown. Mentoring goals for all applicants involve providing both targeted and general guidance and support for grantsmanship, the development of alcohol research programs, and more general professional development issues including feedback on how to mentor their own trainees. Importantly, all four mentees have been incorporated into the applicant's research program which is moving in the direction of youth alcohol intervention and the study of alcohol/HIV interactions. The applicant intends to gain complementary expertise in this area as well as in neuroscience and MRI modalities - all topics of his P60. With respect to the Research Plan, the applicant intends to continue to focus on a research agenda that is broad and yet focused on treatment mechanisms, pharmacotherapy, contextual factors and individual differences. Using his existing data sets he proposes to study mediators and moderators of treatment outcomes and the assessment of daily drinking behavior in the context of his brief intervention work. In addition he will add a study of lab-based alcohol effects onto his ongoing trial of topiramate for heavy drinkers, thus enabling the study of the effects of topiramate and drinking both in the lab (new data to be collected) and in the natural environment (through Ecological Momentary Assessment data that are already collected as part of his ongoing R01). Finally, as funding for his pending P60 application becomes clearer, he will begin pertinent pilot work on aspects of this project.

Public health relevance
PUBLIC HEALTH RELEVANCE: Advancing biopsychosocial approaches to alcohol treatment and mentoring has the potential to influence public health by reducing alcohol use in youth through improved early intervention and treatment. More and better mentored alcohol treatment scientists will facilitate the goal of reduced use in youth. Project Narrative Advancing biopsychosocial approaches to alcohol treatment and mentoring has the potential to influence public health by reducing alcohol use in youth through improved early intervention and treatment. More and better mentored alcohol treatment scientists will facilitate the goal of reduced use in youth. __SpecificAimsTextDelimiter__ RESEARCH PLAN The applicant plans to dedicate 45% of the 75% K Award to advancing his program of research and 30% to mentoring junior alcohol scientists. The applicant is currently funded by NIAAA on two R01s on which he serves as PI. 5.5% effort on "Enhanced MI with Alcohol Positive Trauma Patients" (2R01 AA09892-11) and 4% effort on "Biobehavioral Mechanisms of Topiramate and Drinking (5R01 AA07850-19). The balance of the applicant's effort on each of these projects (10% effort on the Enhanced MI project and 15% effort on the Topiramate project), is covered by the applicant's VA CSA. As mentioned previously, if this K05 application is successful, the PI intends to resign from his VA CSA so as to devote more effort to mentoring non-VA alcohol scientists and to focus on his young adult alcohol interests as well as on his interests in alcohol and HIV. Therefore, should the applicant successfully obtain the K05, 25% of his effort dedicated to his 2 R01s would be "transferred" from his VA CSA to the K05, leaving 20% effort on the K05 for "new" research endeavors. Each of the PI's two major grants represent the current version of the applicant's two main areas of programmatic research: Advances in BIs and biobehavioral mechanisms of pharmacotherapy and craving. These projects are currently funded through the mid to end of 2010, and the applicant will be requesting a no- cost extension for each project. Efforts towards these projects will be expended during the first two years of the K05 Award, if this application is successful. In the interests of full disclosure, the abstracts of each of these currently funded grants are presented below. It is important to point out that the Specific Aims of this application will complement, not duplicate the planned work on these projects. Abstract: Enhanced MI with Alcohol Positive Trauma Patients (2R01AA09892) Alcohol-positive trauma patients are more likely to be readmitted to a trauma center or die from a subsequent injury than are alcohol-negative trauma patients. Despite their increased risk, there are few empirically-supported treatments available for this population. Admission to a trauma unit may represent a "teachable moment", where patients are particularly willing to discuss their alcohol use. Therefore, interventions delivered in the trauma unit may be particularly effective. Motivational Interviewing (MI), a brief, directive, non-confrontational intervention, has demonstrated some promise in this setting. Further, inclusion of a significant other (SO) in prolonged, intensive alcohol treatment appears to improve treatment retention and efficacy. Although inclusion of an SO in MI has been suggested, there are few data to support this endorsement. Accordingly, this study (N=300) will address whether motivational interviewing including both the trauma patient and an SO can more effectively decrease and maintain reductions in alcohol use and alcohol-related problems 6 and 12 months following discharge from the trauma unit than MI with the individual patient or a standard care condition. The 2 MI groups will each receive 2 intervention sessions timed to occur in the hospital, and 1 booster session, occurring 1 month following discharge. In the standard care condition, patients will receive only minimal assessment of their drinking at baseline. This proposal will allow us to address the next phase of our program of research designed to develop easily disseminable treatments for these high-risk populations in medical settings. This study will also address potential mediators of MI, including motivation to change alcohol use, self-efficacy, alcohol treatment attendance, and social support for abstinence. Thus, this study will address both a significant public health problem and provide important information about MI mechanisms that may be relevant to the broader addiction treatment community. Abstract: Biobehavioral Mechanisms of Topiramate and Drinking (5R01AA07850-19) Topiramate (TOP) has been reported to be efficacious in reducing drinking rates in men and women with alcohol dependence in recent studies. The fact that TOP reduced drinking and increased periods of abstinence in non-abstinent alcoholics suggests that it is effective for initiating abstinence (Johnson et al., 2003). However, while significant differences on self-reported drinking measures started at the 200 mg/day dose in week 6, doses continued to increase up to week 8 so the effects of time and dose were confounded. Because TOP requires a slow titration and because the probability of experiencing side effects increases at doses higher than 200 mg/day, it would be valuable to establish efficacy of doses lower than 300 mg/day. In addition, mechanisms that mediate TOP'S effects on drinking are not understood. Evidence suggests that attenuation of craving may mediate TOP'S effects, however, no laboratory studies have assessed urge to drink while on TOP and studies of other putative behavioral mechanisms of effects have not been done. Further, studies have yet to identify which individuals are most likely to benefit from TOP. It has been recognized that improvements in pharmacological treatments may occur through identification of individual difference variables associated with differential treatment response. We propose to randomize participants with alcohol dependence not seeking treatment to one of the following three conditions in a three- group, placebo-controlled design: (1) TOP (200 mg/day); (2) TOP (300 mg/day); (3) placebo. As in our current segment, both Ecological Momentary Assessment (EMA) and cue reactivity (CR) will be measured. EMA will be conducted by having all participants use palm top computers daily for three weeks to record drinking behavior, urges to drink, and environmental circumstances in which urges occur. CR will be assessed in laboratory. The effects of potential genetic moderators of TOP response will be examined, as will certain mediators. This project will provide an efficient and comprehensive analysis of the effects of TOP on drinking and craving and will add important new information about putative biobehavioral mechanisms of TOP's effects. Results will afford a better understanding of whether large-scale RCTs are warranted. 10. Specific Aims This is a new application for a K05 Award that seeks salary support for the applicant to focus on mentoring four highly qualified and relatively junior scientists, to advance research across his two longstanding research programs, to enable him to begin to think through connecting the dots across these areas, to learn new skills, and to begin preliminary work in his new area of interest - alcohol and HIV. Given this comprehensive agenda, the specific aims described are a sampling of the many that will be pursued should an award be granted. In developing these aims, an attempt has been made to develop new research emphases and experimental hypotheses that expand upon work already done or that is in progress and that do not require additional support other than the support of the identified mentees who will be integrated into the Research Plan as appropriate. Though only 5 aims are listed, ideas for other directions to be pursued have been articulated in Section 1B. Space limitations preclude their development here. Aim 1: To evaluate possible moderators of intervention efficacy including gender, salience of the precipitating ED/trauma event (including alcohol-positive/negative status, attribution of alcohol consumption as responsible for the injury/event, aversiveness and perceived seriousness of the injury/event), alcohol use severity, pre- treatment readiness to change, and site (ED vs. Trauma Unit), in the PI's ongoing MI/SOMI trial. Hypotheses: a. Men, participants low in salience (i.e., alcohol negative, low attribution, low perceived seriousness and low aversiveness) and low in readiness to change alcohol use will show greater intervention differences (i.e. greater differences between the intervention conditions) than respective comparisons. b. Participants high in alcohol use severity will show greater intervention differences. c. Trauma patients will show greater effects of MI/SOMI than ED patients. Aim 2: To explore putative mediators of MI's effect on alcohol consumption in the ongoing MI/SOMI trial. Hypotheses: a. Readiness to change, perceived risks/benefits of alcohol use, self-efficacy, and treatment seeking will mediate effects of MI and SOMI. Aim 3: To assess the utility of examining daily drinking behavior in the context of ED and Trauma Unit trials Hypotheses: a. Group differences in drinking data will emerge immediately following the first intervention session and will be further enhanced by the booster sessions. Aim 4: To characterize pre-hospital visit consumption patterns in order to better understand the temporal pattern of drinking in a young adult sample of ED patients. Aim 5: To examine the effects of topiramate (TOP) on craving and other subjective responses to alcohol administration in the laboratory. Hypotheses: a. TOP will reduce self-reported craving for alcohol in response to an alcohol challenge procedure. b. TOP will reduce the stimulating effects of alcohol ingestion compared to placebo.